Mechanisms of membrane trafficking in endocytic and non-endocytic pathways

PROJECT SUMMARY/ABSTRACT
The internalization and recycling of receptors is a key biological process in all eukaryotic cells. The early/sorting
endosome is the initial destination of receptors internalized from the plasma membrane (PM), and serves as a
major sorting station from which receptors are shunted to late endosomes and lysosomes for degradation, or
recycled back to the PM through a transitory network of vesicular and tubular recycling endosomes. Whereas a
decade ago most researchers thought that active sorting directed proteins to the degradation pathways, targeting
to the recycling pathway was thought largely to be a passive process that occurs by default. However, recent
evidence supports active sorting to the recycling pathways by specific sorting nexin (SNX) and other proteins
that bind to the cytoplasmic tails of receptors and specifically target them for recycling. Although recycling is an
essential process for all mammalian cells, the complexities of its regulation are poorly understood including the
sorting of receptors on endosomal membranes, the budding and fission of vesicles and tubules from the
endosome, and the transport of receptors back to the PM. As such, our knowledge of endosomal function lags
significantly behind that of receptor internalization mechanisms.
A key group of regulatory proteins that controls sorting and trafficking at the endosome is the retromer complex.
Originally identified in the retrieval of biosynthetic cargo from endosomes to the Golgi complex, the retromer has
recently been implicated in the regulation of a variety of key cellular pathways both within and outside the scope
of endocytic trafficking including endocytic recycling, mitochondrial homeostasis, the centrosome cycle and
ciliogenesis. The retromer complex also interacts with other key endocytic regulatory proteins, including the
tubular endosome scaffold MICAL-L1, its interaction partner and endosomal fission modulator, Eps15 Homology
Domain protein 1 (EHD1), and a host of sorting nexin SNX proteins that mediate endosomal cargo sorting.
Retromer also links to the actin cytoskeleton via the WASH complex. Our laboratory has been focusing on an
overall understanding of the mechanisms by which endocytic regulatory proteins function both in endocytic
pathways and in non-endocytic trafficking. In particular, we will address significant and as-yet-unresolved
biological problems such as: i) How endosomal fission is regulated and linked to sorting and recycling, and ii)
How key endocytic proteins mediate the biogenesis of the primary cilium.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it addresses our basic understanding of membrane trafficking, a process that controls the localization of cell surface receptors and their signaling, mitochondrial homeostasis, ciliogenesis, centrosome duplication and cell division, and a host of other key cellular events. Accordingly, enhancing our knowledge of these processes is likely to lead to new opportunities to improve human health, consistent with the mission of the National Institutes of Health.